CCPS Program

ABSTRACT – CANCER CONTROL AND POPULATION SCIENCES PROGRAM
The central themes of the Cancer Control and Population Sciences Research Program (CCPS) at the Duke
Cancer Institute (DCI) are to reduce the cancer burden in the DCI catchment area, with particular attention to
cancer health disparities, and to foster collaboration with other DCI researchers, health systems, and
communities. CCPS galvanizes and guides its researchers by organizing around two Focus Areas: (1) Risk
Identification and Reduction; and (2) Patient Outcomes and Survivorship. These Focus Areas are aligned with
our first two Specific Aims. The first Aim is to identify causes of cancer and design programs to reduce cancer
risk in our catchment area. Our primary objectives for Aim 1 are to: 1) discover novel aspects of risk factors and
biomarkers to improve risk prediction; 2) refine screening guidelines to maximize gains and minimize harms; and
3) develop and implement programs to promote healthy behaviors. Our second Aim is to optimize cancer care
delivery starting with diagnosis, through treatment, survivorship, and palliative care. Our primary objectives for
Aim 2 are to: 1) develop cutting-edge interventions to enhance cancer patient and family members’ experiences;
2) use eHealth/mHealth and other new technologies to improve symptom management and outcomes for cancer
patients; and 3) conduct innovative trials and research to improve transitions of care and end-of-life support. Our
scientific efforts span the cancer care continuum from primary prevention to palliative care. CCPS provides a
broad spectrum of resources to its members to facilitate collaboration and to address the needs of our catchment
area. Our scientific areas for future growth include a focus on onco-primary care, infectious diseases and cancer,
cardio-oncology, data science, and cancer and aging. Our third Aim is programmatically-focused, and we seek
to support collaboration and education. We specifically aim to increase collaborations across DCI to address
catchment area priorities and to provide more formal training of our junior investigators. Value added of CCPS
to the DCI includes facilitating DCI-wide working groups that bring CCPS members together with other DCI
program members to address important topics, such as sexual health of cancer patients, tobacco, childhood
cancer, and cancer and aging.
CCPS is comprised of 49 primary members and 19 secondary members from 12 departments and 5 schools
within Duke University. Total direct funding for primary program members is $14.5M, of which $11.6M is peer
reviewed, including $3.5M from the NCI. From 2014 through 2018, primary program members published 1,518
papers in peer-reviewed journals, 26% were intra-programmatic and 27% were inter-programmatic
collaborations. During the current grant period, the program enrolled 3,308 participants to all trials, 1,647 to
interventional trials, and 161 to treatment trials. Overall, CCPS is an active and collaborative program whose
research is vision-driven, responsive to the needs of our catchment area, and whose members’ work has had a
direct impact on national guidelines and statewide policies that influence cancer care and the cancer burden.